Physical determinants of DNA recognition and genome organization in crowded environments

Abstract
The proposed research program seeks to understand how genomic information is organized and accessed. At
the core of my proposal is an effort to develop a framework that bridges in vitro experiments to their counterparts
in vivo. We will do this by employing novel in vitro experimental platforms that are uniquely poised to work with
mesoscale materials. (1) DNA and chromatin curtains, which are a high-resolution, high-throughput single-
molecule tool for imaging interactions on long extended DNA and chromatin fibers. (2) Optical tweezers, which
measure forces on DNA or chromatin to exceptionally high resolution. And (3) droplet experiments, which allow
us to measure key biophysical parameters, like free energies, partition coefficients, and relative mobilities. Using
these assays, research in my lab is aimed at understanding how chromatin condenses into compact structures
and the role that compaction plays in biology. In addition, we are investigating how epigenetic information is
propagated along chromatin fibers and how chromatin dynamically partitions into regions of similar function in
the nucleus. The proposed research program seeks to connect in vivo measurements into mechanistic
frameworks of individual protein actions by tracing reactions across scales. Specifically, our approaches afford
us the opportunity to increase the complexity of a particular reaction from isolated molecules in a test tube, to
one dimensional reactions on extended molecules, to the disordered three dimensional environment of
condensates, and finally to the nucleus. We feel that stepping across scales in our investigations, stopping at
these intermediate levels of observation, which up to now have been missing, will allow us to successfully attack
important questions in chromatin biology about regulation and domain formation, which have remained elusive.
And ultimately, will drive us toward a cohesive model of how our genetic information is accessed, managed, and
packaged.

Public health relevance
Project Narrative The proposed research program seeks to understand how genomic information is organized and accessed by direct observation across scales—from single molecules to mesoscale reactions toward behaviors in living nuclei. The organization and structure of chromatin in the cell of often dictates when and how DNA sequences are processed and perturbing chromatin architecture can lead to misregulation of genes, errors in differentiation and development, and genome instability, all of which lead to a host of maladies in living organisms. By connecting newly accessible in vivo measurements into mechanistic frameworks of individual protein actions, many long-standing problems in chromatin biology are likely to be resolved.